GAS6-mediated alveolar bone regeneration - Admin Supplement

PROJECT SUMMARY (Parent Award)
Tooth loss from trauma or disease remains a significant world-wide concern due to poor esthetics and loss of
function. Addressing this issue is not trivial because regeneration of alveolar bone and oral tissue is not
predictable, partially due to the complexity of the process. Bone regeneration of these defects remains
unpredictable and understanding the physiological mechanisms that guide bone marrow biology and
inflammatory resolution will increase the therapeutic reliability of these regenerative techniques in the future.
We have observed a previously unknown role for Growth Arrest Specific 6 (GAS6) in controlling alveolar bone
and soft tissue regeneration following extraction. GAS6-deficient mice showed markedly worse healing
following extraction, which was associated with aberrant bone and immune phenotypes. The primary goal for
this proposal is to test the critical role of GAS6 in alveolar bone healing. Two specific aims are proposed
based on our previous observations. We hypothesize that GAS6 signaling affects the priming of mesenchymal
stem cells towards the osteoblastic lineage. This hypothesis will be tested through measurement of healing
following extraction in mice with mesenchymal stem cells deficient in GAS6 signaling, along with associated
experiments on primary cells derived from patients following extraction. We also hypothesize that increased
neutrophil infiltrate in GAS6-deificiency impedes alveolar bone regeneration. We will employ models
conditional knockout models of neutrophils and neutrophil functions to test this hypothesis. This award will
provide a significant contribution to the understanding of the physiology of healing in the oral cavity while
providing significant training to the candidate in the use of genetic mouse models and immunology, ultimately
leading to an independent career as a dental clinician-scientist specializing in treatment of systemically
compromised patients.

Public health relevance
PROJECT NARRATIVE (Parent Award) Regeneration of oral tissue lost to trauma or disease is not predictable, partially due to the complexity of the process. Functional healing of oral defects remains unpredictable and understanding the physiological mechanisms that guide bone marrow biology and inflammatory resolution will increase the therapeutic reliability of these regenerative techniques in the future. This study aims to characterize the GAS6 pathway related to oral tissue regeneration through two principal aims: 1) induction of osteoblastic activity and 2) inflammatory resolution.